Investigating the structure, function, and regulation of polyamine acetyltransferases

PROJECT SUMMARY/ABSTRACT
Polyamines and the enzymes that regulate them are critical for numerous cellular processes in all domains of
life. These molecules are flexible, positively charged, and can be used to modify proteins, bacterial cell wall
polysaccharides, aid antibiotic resistance, and act as scaffolds to create new molecules like siderophores and
toxins. They help control expression of different genes during stressful situations, and they are often signals for
bacterial biofilms or indicators for problems in human health. Polyamine acetyltransferases (PAATs) serve to
partially neutralize the charges of these molecules, but we are beginning to find new ways these enzymes are
being regulated and function in different organisms. My laboratory studies these PAAT enzymes and tries to
understand how they look and how they work from structural, functional, and regulatory perspectives in
different bacterial pathogens and other non-pathogenic organisms. Based on our work in the previous funding
period, we have identified new avenues for exploring these properties of PAATs. We envision building on our
previous work to expand our fundamental knowledge in the field and address the following questions during
the next funding period: 1) Which sequence and/or structural attributes contribute to PAAT substrate specificity
and oligomerization?, 2) Which PAAT residues dictate polyamine acceptor substrate and acyl donor substrate
specificity, and 3) How are PAAT proteins regulated? The results of these studies will help establish key sites
on bacterial PAATs that can be targeted for drug development that are not redundant in human homologs and
help us more fully understand the fundamental roles these enzymes play in a variety of cellular processes and
communities.

Public health relevance
PROJECT NARRATIVE Polyamines have extensive roles in viral and bacterial infections, including antibiotic drug resistance, and human diseases such as Heart Disease, Neurodegenerative Diseases, and Cystic Fibrosis. Understanding more about how these molecules are regulated by polyamine acetyltransferase enzymes across domains of life will provide new insight for targeted drug development and deepen our fundamental knowledge about how living organisms handle diverse polyamines they encounter from different environments.